Investigating Career & Research Experience Access Through Evidence (iCREATE)

Enter the text here that is the new abstract information for your application.
There is an urgent need to increase the number of prepared graduates joining the biomedical workforce through systematic and impactful evidence-based approaches that follow scientific practices. Florida International University's Project iCREATE (investigating Career & Research Experience Access Through Evidence) will increase awareness of biomedical careers as well as workforce readiness for future biomedical careers by designing, implementing and testing innovative interventions; as well as investigating the effect of high-impact practices (e.g., different research experience formats and career development opportunities) on students' career goals, career strategies, and key student career intent and action outcomes. FIU is an urban research-intensive (R1) public institution with over 4,000 biology students. iCREATE centers on generating evidence for two scalable interventions that will leverage FIU's extensive expertise in student success and focus on programming that transforms students' access to biomedical research experiences and career awareness and preparation. iCREATE aims to 1) develop and implement the following interventions: Careers+, a workshop for students focused on career development strategies and biomedical career awareness, and CURE+ which expands a one semester CURE into a two-semester advanced course-based research experience; 2) evaluate the effectiveness of the proposed interventions and current research experiences available to students at our institution; and 3) perform a qualitative longitudinal study of undergraduates’ development of career goals and strategies and the impact of research experiences and career development opportunities on student career goal trajectories. iCREATE will advance our understanding of best-practices in preparing a qualified biomedical workforce by 1) developing and testing evidence-based programs, thus, laying the groundwork for implementing similar efforts in life science curricula to increase student preparation for the biomedical workforce; 2) conducting comparative analyses across research experience formats to directly compare the impact of various experiences on student outcomes; 3) focusing on the impact of research experiences and career development opportunities on students, and 4) following students longitudinally to comprehensively understand how students develop career strategies and factors that trigger the intent and actions to pursue a career in biomedical research.

Public health relevance
Project iCREATE (investigating Career & Research Experience Access Through Evidence) will design, implement, and test, two scalable and innovative interventions to increase awareness and preparation to biomedical careers; as well as investigate the effect of various research and career development experiences on students' career goals, career strategies, and key student career intent and action outcomes. The desired outcome is to enhance the evidence base for effective interventions and contribute to the growing knowledge on elements that impact students' intent and preparation to pursue biomedical research careers.